Cancer Pathophysiology: Integrating the Host and Tumor Environments

? DESCRIPTION (provided by applicant): Support is requested for a Keystone Symposia meeting entitled Cancer Pathophysiology: Integrating the Host and Tumor Environments, organized by Sheila A. Stewart, Sandra S. McAllister and Lisa M. Coussens. The meeting will be held in Breckenridge, Colorado from March 28-April 2, 2016. The local and systemic tumor microenvironments (TME) play a pivotal role in all stages of cancer development, including initiation, malignant conversion and metastasis, as well as regulating how neoplastic cells respond to cytotoxic, targeted and immune-based therapies. Research over the last decade has revealed the incredible diversity and plasticity that constitute the TME. Thus, the focus of this meeting will be to bring together a wide range of experts who focus on the various aspects of the TME with the intent of creating a more complete picture of the potential therapeutic landscape. The unique feature of this meeting is its breadth of experts focused on both the systemic and local TME, who also recognize varied paracrine interactions with heterogeneous neoplastic cells. Presentations will focus on emerging studies, enabling attendee's access to senior investigators, as well as new investigators spanning the diversity of disciplines called cancer biology.

Public health relevance
PUBLIC HEALTH RELEVANCE: The first 200 years of cancer research focused on identifying how a normal cell is altered to become a tumor cell, with the idea that by understanding cell intrinsic alterations, effective therapeutic targets would be identified. More recently, it has become clear that the tumor microenvironment (TME) is a key partner in the transformation and progression processes, as well as the development of therapeutic resistance. Given the pivotal role the TME plays in cancer, this Keystone Symposia meeting on Cancer Pathophysiology: Integrating the Host and Tumor Environments will bring together a diverse, international group of scientists who focus on how the TME participates in all stages of cancer development.